EFFECTS OF HOME AND OUT-OF-HOME CARE IN CHILD DEVELOPMENT

This project involves a longitudinal study conducted in Sweden examining the effects of center day care, family day care, and home care on the development of 145 children recruited at an average of 16 months of age. Multivariate analyses consistently indicated that type of care had no reliable impact on the children one and two years post-enrollment. The quality of home care and the quality of alternative care had equivalent effects on personality maturity, compliance, and emergent social skills with peers and adults. Quality of home care, but not participation in daycare, was found to predict aggression and noncompliance at 28, 40, and 80 months of age. Levels of aggression were moderately stable over time. A second study revealed weak associations between infant daycare and the security of infant-mother attachment. Longitudinal analyses of data from the NLSY revealed that children who experienced at least two years of daycare prior to age three did not differ from children who did not experience daycare. When SES was controlled, maternal role satisfaction was a significant predictor of behavior problems and academic achievement among 5- to 13-year-olds.